RNA tools for probing spliceosome dynamics

Project Summary/Abstract
Alternative splicing is a central mechanism to diversify genetic information on the post-transcriptional level.
Advances in sequencing technologies revealed shifts in alternative splicing patterns as key features in a variety
of biologically relevant systems including embryo development, the adaptive immune response and cancer
progression. A recent RNAseq study demonstrated that alternative splicing patterns for thousands of transcripts
are altered in macrophages infected with Listeria. While proteins and mechanisms involved are not established,
a protective cellular response to limit intracellular replication may be a consequence. The central goal of this
proposal is to use this infection model system to gain insights into dynamics of non-coding RNAs and
mechanisms of alternative splicing on a single cell level. Intriguingly, it was independently discovered that
spliceosome components are transiently sequestered in cytosolic RNA-protein granules called U-bodies during
Listeria infection, suggesting that spatiotemporal sequestration may contribute to alternative splicing regulation.
Infection with Listeria and formation of U-bodies are highly heterogeneous both in space and time and ideally
must be assessed on a single-cell basis. Fluorescence microscopy offers the possibility for long-term
visualization of tagged proteins and fluorescently labeled pathogens, but robust tools to visualize cellular RNAs
are limiting. To enable visualization of non-coding RNAs, a versatile tool to fluorescently label RNA in live cells
will be developed (Aim 1). This tool will then be utilized to quantify spatiotemporal dynamics of U-bodies and
simultaneously monitor Listeria replication (Aim 2). Contributions of spliceosome components will be dissected
by monitoring RNA dynamics and Listeria replication as spliceosome components will be manipulated
experimentally. Lastly, a time resolved quantitative mass spectrometry approach will be used to identify protein
candidates that regulate re-shaping of the alternative splicing landscape (Aim 3). These candidate factors will
be further investigated by knockdown and assessing consequences for U-body dynamics and intracellular
bacterial replication in the microscopy assay. Together, this study will serve as a unique model system to unravel
alternative splicing regulation on a single cell level in a physiologically relevant model system using fluorescence
microscopy.

Public health relevance
Project Narrative Alternative splicing greatly increases the diversity and complexity of genetic material and has been implicated in numerous disease states, yet insights in the proteins, pathways and mechanisms that govern this complex layer of gene regulation are only beginning to emerge. Bacterial infection represents a physiologically relevant cellular perturbation that triggers elaborate alternative splicing changes with consequences for intracellular bacterial replication. A novel RNA fluorescence tags and a multi-parameter single cell microscopy assay will be developed to investigate dynamics of RNA and protein components of the spliceosome and interrogate re-shaping of the alternative splicing.